HIGH RESOLUTION STUDIES ON NEURONAL CYTOSKELETON

Date from our laboratory suggest that neuronal microtubules are transported from the centrosome into developing axons. We hypothesize that the microtubules move against actin filaments. SEM is a powerful tool for studying topographic structure.We would like to investigate this possibility by obtaining high resolution SEM images of the neuronal cytoplasm.